Neuroinflammation and Modulating Factors in Depression and HIV

PROJECT SUMMARY/ABSTRACT
Depression in HIV is associated with worse HIV outcomes including worse engagement in care, medication
adherence, and retention in care. Depression is also three times more prevalent in those with HIV than in the
general population. While there are complex reasons including psychosocial, there is a growing body of
evidence that inflammation is linked to mental illness including depression although the underlying
pathophysiology in people living with HIV is not well understood. Better understanding of the pathogenesis will
help identify new treatments. Better depression treatments may thereby lead to engagement/retention in care
and better HIV outcomes including virologic control. Better HIV control will help achieve the UNAIDS 90/90/90
goals to diagnose 90% of all HIV-positive persons, provide ART for 90% of those diagnosed, and achieve viral
suppression for 90% of those treated.
The Specific Aims of this K23 award are: 1) To determine if CSF inflammation and neuronal damage are
associated with depression in HIV-infected Ugandans and 2) Determine if the prevalence of depression at 26
weeks of HIV therapy is improved with group psychotherapy and antidepressant medicine over antidepressant
medicine alone and determine if the persistence of depression is associated with higher levels of innate
inflammation due to the systemic stress response. I hypothesize that depression is associated with
dysregulated innate inflammatory signaling in CSF in HIV-infected persons. I also hypothesize that in HIV-
infected Ugandans with CD4 <200 cells/L and depression initiating HIV therapy, those with persisting
depression at 26 weeks will have increased plasma interleukin-6 and cortisol compared to persons whose
depression resolves. I further hypothesize that structured weekly group psychotherapy will reduce depressive
symptoms, measured by patient health questionnaire-9 (PHQ-9) at 26 weeks of HIV therapy.
Dr. Lofgren’s long-term career goal is to become an independent translational researcher who bridges the
gap between mental health and immunology, moving basic science concepts to clinical application in resource-
limited settings. During her training to date, Dr. Lofgren has spent three years performing clinical research in
East Africa, and all of the last two years divided between Minnesota and Kampala, Uganda. This K23 award
will provide for mentored career development using a combination of coursework to supplement current
knowledge gaps and practical mentored-research experience to build a strong foundation of research skills in
mental health, immunology and neuroscience. This will allow her to be an expert in psychoneuroimmunology.
The award will build upon existing international collaborations allowing the candidate to apply her K23 training
into clinical and translational research among persons living with depression and advanced HIV/AIDS with
CD4<200 cells/L.

Public health relevance
PROJECT NARRATIVE Depression is three times more common in those with HIV than the general population, and depression is associated with worse HIV outcomes including engagement in care, medication adherence, and retention-in-care. Inflammation is linked with depression in many chronic diseases including HIV. Yet there is a paucity of data on the underlying pathophysiology of how inflammation is in the pathway to depression in HIV or how inflammation changes over time.